The PET Radiotracer Translation and Resource Center (PET-RTRC) Admin Core

Administration Core Project Summary
During the current funding cycle the Administration Core has been fully operational fulfilling its organizational,
financial management, and communication functions, ensuring the PET Radiotracer Translation and Resource
Center (PET-RTRC) met its scientific, training, and dissemination goals. In this renewal application it will continue
to provide these services and has added innovations to further enhance Center performance. Key components
of the Core include:
1) Administrative Component: The administrative component coordinates the general activities of the PET-
RTRC, including infrastructure and financial support to facilitate communication within the PET-RTRC located
at WU, between the WU location and our various Collaborative Projects (CPs) and Service Projects (SPs)
located around the country, and between the Center and NIBIB, as well as organize the PET-RTRC annual
meeting.
2) Provide biostatistical support for Center activities.
3) The Quantitative Imaging & Informatics Resource Quantitative Imaging & Informatics Resource (QI2R): In the
renewal application, QI2R will expand operations and enhance the objectives with the goal to ensure timely
and standardized evaluation of radiotracer performance, data management and to provide additional
assistance to sites to establish their pre-clinical imaging capability.
4) Expanded relationship with the Office of Technology Management (OTM): In the renewal the Center will fortify
its relationship with OTM. This is necessary to enhance not just patent and licensing opportunities, but also
the intellectual pipeline across sites.
5) Continue the Tracer Review Committee (TRC): The committee provides broad overview and guidance on the
performance of the various radiotracers under development at the Center.
6) Continue the Executive Committee: This committee will perform the major oversight functions of the PET-
RTRC and will be composed of the Program Director and TR&D and Core Leaders and Co-Leaders.
7) Continue the External Advisory Committee (EAC): The committee is composed of 5 experts who are scientists
knowledgeable in the key components relevant to the development and/or translation of radiotracers and/or
training of radiochemists and/or the application and use of radiotracers for medical imaging. It provides input
on the scientific and operational direction of the PET-RTRC. It prepares a written report of its
recommendations that will be incorporated into the PET-RTRC’s Annual Progress Report provided to the
NIBIB program.

Public health relevance
Administration Core Project Narrative Per the instructions in PAR-20-169, please see Overall Project Narrative.